Regenerative engineering for complex extremity trauma

PROJECT SUMMARY
The clinical treatment of limb threatening injuries requires complex surgical management and a lifetime
of corrective surgeries and physical therapy. There is an unmet clinical need for regenerative approaches that
can functionally repair both muscle and adjacent bone. Our prior research has shown that spatial patterning cues
from nanoscale extracellular matrices modulate the cellular inflammatory phenotype, angiogenic potential, and
skeletal muscle myogenesis. We have further shown that when these patterned materials are combined with
running exercise, that large volumetric muscle injuries in mice can be regenerated comparable to native tissue.
Therefore, the goal of the parent grant, was to define the regenerative relationship between bone and muscle
healing as well as couple engineered muscle with free running exercise to enhance local tissue regeneration.
The overarching research goal of this supplement is to identify the characteristics of an optimal exercise regime
for rehabilitation and regeneration after complex traumatic injury and co-treatment with an engineered muscle.
This will be explored through the application of a comprehensive post-injury exercise regimen that varies in
duration, frequency, intervention type, and timing. The proposal first examines the contribution of exercise
frequency (sessions per week) and duration (length of each session) on tissue regeneration and limb functional
recovery. This approach will allow us to determine the impact of fatigue and recovery time on a diverse set of
healing outcomes which include in situ muscle force production, microCT imaging to evaluate bone density and
volume, dynamic weight bearing and tactile allodynia to assess mobility and pain, and systemic inflammatory
cytokine profiling. We will also examine how different forms of exercise intervention (contraction and loading)
and timing (how soon after injury) guide these same regenerative outcomes. The research outcomes of the
proposed body of work for this supplement will: 1) generate new data on rehabilitation protocols that extends
beyond free running; 2) expands the capacity of healing metrics to examine dynamic weight bearing and pain
sensitization as primary functional health assessments; 3) characterizes the immune profile of circulating
cytokines in response to injury and exercise. The proposed studies will establish an effective rehabilitation
protocol that works in concert with our engineered muscle therapy to enhance the regenerative response to
rehabilitation therapies following severe musculoskeletal injury. This award supplement will provide training in
research and career development to support the mission of promoting diversity in health-related research. The
proposed candidate, Joshua Vanderpool, will receive training in muscle biology, biomaterial fabrication, cell
culture, exercise physiology, animal injury and behavioral models, in vivo imaging, histology, and image analysis.
Additionally, they will receive guided career development through a formalized Individual Development Plan,
attendance of professional writing and innovators workshops, presentation of research findings at conferences,
continued training in ethics, and opportunities for peer mentorship and student leadership experience.

Public health relevance
PROJECT NARRATIVE Advancements in the treatment and functional restoration of composite bone-muscle traumas are hindered by a lack of available therapies that can repair both of these tissues together. In the parent grant, we proposed to engineer regenerative materials that work in concert with the body’s healing programs and physical rehabilitation to restore the structure-function relationship within and between damaged muscle and bone. The goals of this Research Supplement to Promote Diversity in Health-Related Research are to: 1) to train a highly innovative biomedical engineering graduate student to integrate concepts in biomechanics with regenerative rehabilitation models in musculoskeletal research; 2) determine the impact of load-bearing exercise on muscle/bone regeneration after traumatic injury; 3) evaluate the contribution of exercise intervention timing and intensity on the systemic inflammatory response and functional limb recovery.